Research Training Program in Behavioral and Biomedical Sciences

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The Research Training Program in Behavioral and Biomedical Sciences (BBS) at West Virginia University is
designed to provide advanced research training at the interface of behavioral and biomedical sciences to PhD
students planning careers as independent investigators. The BBS Program draws on existing, high-level
training in the Biomedical, Psychology, Biology, and Public Health PhD Programs and provides considerable
added value through curricular offerings (including behavioral neuroscience methods, biostatistics,
bioinformatics, and epidemiology), a highly interactive journal club and an extensive seminar series. Specific
interdisciplinary training and experiential activities are provided to foster scientific leadership, communication
skills, responsible conduct of research, professional development, advanced training in methodological rigor
with attention to reproducible research, and cognizance of issues related to human health, physiology, and
disease. Structuring the BBS Program to leverage the strengths of the Biomedical, Psychology, Biology, and
Public Health PhD Programs ensures an experienced and productive preceptor group, a wide range of
research training opportunities, and a highly qualified applicant pool. The BBS Program provides a proven vehicle for training the next generation of scientists with the intellect, knowledge, experience, resilience, and courage to address complex research problems with significant

Public health relevance
The Research Training Program in Behavioral and Biomedical Sciences (BBS) at West Virginia University prepares scientists for successful careers conducting research across scientific disciplines. Trainees learn transferable skills needed to address significant public health issues related to human behavior or behavioral risk factors for disease. Training focus areas include addiction, neuropsychiatric and neurological illnesses, cancer, stress, and aging, all of which represent major societal burdens in West Virginia and the broader Appalachian region.